Mechanism of VCP interaction and processing of neurodegenerative tau fibrils

Project Summary
The goal of this proposal is to study the structure and dynamics of the interaction of the AAA+ ATPase,
valosin-containing protein (VCP) with disease-relevant tau fibrils to determine VCP-mediated disease
progression and therapeutic potential. Alzheimer's Disease (AD) and Corticobasal degeneration (CBD) are 2 of
more than 20 “tauopathies” characterized by different forms of fibrillar tau aggregates. The degree of tau
pathology on autopsy correlates with cognitive decline, yet the mechanism of neurotoxicity, disease
development, and disease progression in tauopathies remains to be elucidated. Diseases of aggregation
indicate a dysfunction in proteostasis – the regulation and balance of the proteome. VCP plays an essential
role in proteostasis by removing proteins from complexes, membranes, and aggregates such as those formed
by fibrillar tau, thus pointing to VCP as an important player in proteostatic dysfunction and as a potential drug
target for tauopathies.
VCP has a variety of cofactors that enable it to perform an array of vital cellular. Ufd1 and Npl4
cofactors (UN) together specifically enable VCP to recognize poly-ubiquitinated substrates. AD tau fibrils have
high rates of ubiquitination, likely because cells have marked these fibrils for removal by proteins such as VCP.
Additionally, mutations within VCP are linked to neurodegenerative disease. A hypoactive VCP mutation first
described by the Edward Lee lab clinically presents as dementia and has been shown to promote tau fibril
pathology. The hypoactive VCP mutation is thought to reduce VCP function causing the accumulation of tau
fibrils, leading to neurodegenerative disease. However, a similar mechanism of VCP inadequately clearing tau
fibrils may be present in cases of sporadic tauopathies. VCP/UN, mutant or wild-type, may also get stuck on
tau fibrils (possibly due to fibrils' high stability) and be unable to break down the fibril or be released, reducing
effective VCP function by trapping it on the fibril. This has been seen with a similar AAA+ ATPase in the 26S
proteasome and neurodegenerative aggregates.
I propose that for productive disaggregase activity VCP/UN binds unstructured ubiquitin at either end of
tau fibrils then pulls off one tau monomer at a time. I also propose the mechanism of action will not change but
the stoichiometry and rate of reaction will change between tau fibrils due to differences in fibril structure and
ubiquitination. To test this model, in Aim 1 I will structurally characterize how VCP/UN interacts with brain-
derived AD and CBD tau fibrils. Structurally understanding how VCP/UN interacts with tau fibrils will help
elucidate the protein regions that are crucial to VCP/UN function, and knowing how this interaction changes
with fibril type will help understand the generalizability of the VCP/UN fibril interaction. In Aim 2, I will
characterize the dynamics of the VCP/UN-tau interaction. Understanding the dynamics of VCP/UN interaction
with these fibrils will further elucidate the mechanism of VCP/UN in relation to disease-relevant tau fibrils.

Public health relevance
Project Narrative Alzheimer's Disease and Corticobasal degeneration are 2 of more than 20 “tauopathies” that are characterized by different forms of fibrillar tau aggregates and lack basic understanding of mechanism of neurotoxicity, disease development, and disease progression. Valosin-containing protein is an essential factor in proteostasis, the regulation and balance of the proteome, through removing proteins from complexes, membranes, and aggregates such as those formed by fibrillar tau and has recently been linked with a newly discovered tauopathy. This application proposes to obtain the first structures of valosin-containing protein with brain-derived tau fibrils from Alzheimer's Disease and Corticobasal degeneration patients and probe the mechanism of how valosin-containing protein interacts with brain-derived and recombinant tau fibrils.